Fitness Effects of Beneficial Mutations

Project Summary/Abstract
The progression of cancer and infectious disease is an evolutionary process. Pathogens engage in an arms
race with their hosts, and while antibiotics/antivirals have enabled us to skew the outcome of these contests,
these bulwarks against contagion are being steadily eroded. Mutation and natural selection, coupled with rapid
generation times and immense pathogen population sizes, provide pathogens a decisive advantage. To regain
the upper hand, we must better understand the evolutionary process, to aid in the development of novel classes
of antimicrobials and devise therapeutic strategies that take into account how these weapons work and how
pathogens evade them. Until recently, efforts to gain a deep understanding of the adaptive process were stymied,
because adaptive mutations are rare and identifying them is challenging. To solve this, we developed a system
to track the evolutionary process, isolate thousands of adaptive lineages, remeasure the fitness of those lineages
across many environments, and cheaply whole genome sequence hundreds to thousands of such mutants.
I propose a new phase in my ambitious, integrated research program that takes full advantage of this lineage
tracking system, and our discovery of Pareto fronts, which are indicative of trade-offs. We will pursue two major
goals. First, we will expand our understanding of evolution in the face of abiotic selection pressures, especially
those that produce adaptive trade-offs. Specifically, we will determine the role of historical contingency as it
pertains to trade-offs in adaptation, the potential for trade-offs to force canalization (e.g., trapping lineages into
extreme specialization), the influence that epistasis exerts on the geometry of trait space, and the extent to which
adaptive constraints underlie negative and diminishing returns epistasis. Second, we will expand to contrast
these findings with evolutionary outcomes under biotic selection pressures, using two new systems. To model
genetic conflict and arms race dynamics within species we will use the killer yeast system. Killer yeast secrete a
toxin that destroys sensitive yeast, while retaining an intracellular antitoxin. Toxin and antitoxin are both encoded
by a vertically inherited virus, which itself parasitizes a second virus. We will co-evolve killer and sensitive cells
and determine whether, as theory predicts, there are recurrent periods of selection and whether coevolved
solutions show greater trade-offs than typically observed from abiotic selection pressures. To experimentally
model arms race dynamics between species we will use crAssphage, one of the most prevalent bacteriophages
associated with the human gut microbiome. The aim of these evolution experiments will be to evaluate the
dynamics of phage and its bacterial host co-adaptation over trials of short- and medium-term duration. Overall,
this integrated, multi-level research strategy will yield fundamental new insights into how the adaptive process is
constrained under alternative forms of selection. Armed with this deeper understanding of adaptation, we will
better be able to predict the likelihood of different evolutionary futures given knowledge of a genomic present
and thereby gain the upper hand in our battle against human disease.

Public health relevance
Project Narrative Evolution underlies the emergence of drug resistance in infectious diseases, as well as the progression of cancer. This research will characterize and contrast evolutionary outcomes and their trade-offs from both abiotic and biotic selection pressures. A detailed understanding of such evolutionary outcomes opens the possibility of predicting evolutionary trajectories and improving the design of multi-drug therapy for better patient outcomes.